Resue of CF phagocyte function with CFTR modulator therapy

PROJECT SUMMARY
Why patients with cystic fibrosis (CF) continue to suffer from chronic bacterial infections despite
new medications that improve CF transmembrane conductance regulator (CFTR) function is
unknown. The objective of this proposal is to define how new triple combination highly effective
CFTR modulator therapy (HEMT) alters CF phagocytic cell function. The rationale underlying
this proposal is that our prior work demonstrates that CF macrophages and neutrophils are
integral to the inability of patients with CF to clear bacterial infections through several
dysfunctional mechanisms. Many of these mechanisms are only partially amenable to
treatment with currently available CFTR modulators. The central hypothesis is that CF
phagocytic cell function is dependent on functional CFTR, can be restored by HEMT, and
correlates with clinical responses. The central hypothesis will be tested by pursuing three
specific aims: 1) Determine whether HEMT changes functional CFTR in CF macrophages and
neutrophils; 2) Assess HEMT-treated macrophage and neutrophil functional responses to
infection; and 3) Correlate individual clinical responses with phagocytic cell function. We will
pursue these aims using unique models and assays that include human macrophages and
neutrophils and association with well-characterized clinical data. The proposed research is
significant because a precise understanding of how CF macrophage and neutrophil function is
regulated by HEMT would allow novel, personalized treatment approaches to infection in CF
and other diseases. The expected outcome of this work will establish a mechanistic framework
to enable us to target and correct defective killing of bacteria in CF. The long-term goal is to
develop therapeutics that modulate host immune responses in CF patients to mitigate chronic
infection and inflammation. Ultimately, we will translate this new knowledge into a new treatment
paradigm that uses innovative host-directed therapies to combat bacterial infections.

Public health relevance
PROJECT NARRATIVE Cystic fibrosis (CF) remains one of the most common, life-limiting genetic disorders due to chronic bacterial lung infections that do not respond to traditional antibiotic therapy. The proposed research will help us achieve a thorough understanding of how the immune system responds to treatment with novel CFTR modulators, and how these responses correlate with important clinical outcomes. The proposal is relevant to public health and the NIH’s mission as the findings will impact the treatment and understanding of immunodeficiencies and lung diseases associated with chronic bacterial infections and genetic or acquired CFTR dysfunction.